TGF-β signaling and regulation: Elucidating molecular mechanisms and pathogenic functions of the ‘co-receptor’ Cripto-1 and the receptor BMPRII

PROJECT SUMMARY
TGF-β family proteins are critically important for human health. They regulate differentiation, proliferation and
homeostasis in normal cell physiology, but mutations or abnormal expression are associated with devastating
diseases, including cancers, and Pulmonary Arterial Hypertension (PAH). Discovering therapeutics that target
TGF-β family proteins is an urgent priority and will have a great impact on human health. However, identifying
therapeutics has been difficult, because the physiological and pathological activities of TGF-β family proteins
are poorly defined. A profound molecular understanding of TGF-β family action is essential to overcome these
obstacles. Thus, the overarching goal of the lab is to determine how TGF-β family signaling is regulated and to
link our findings with physiological and pathological processes. We blend tools of structural biology,
biochemistry and cell biology. Here, we have two aims. In Aim 1 we will validate the newly established
mechanism of ligand recognition by Cripto-1 family co-receptors and examine the roles of membrane-anchored
and soluble Cripto-1 in cancers. Cripto-1 is a membrane-anchored, EGF-CFC family `co-receptor' that
promotes tumor progression. It can both potentiate and inhibit TGF-β family signaling. But how Cripto-1
mediates these opposing activities is not clear. Our recent studies suggest a mechanism. Cripto-1 blocks
binding of TGF-β family ligands to receptors. Thus, a soluble form inhibited signaling. But membrane-anchored
Cripto-1 potentiated signaling and promoted tumorigenesis. We hypothesize that membrane-anchored Cripto-1
captures ligands at the cell surface and directs ligands into endosomes for signal potentiation and oncogenic
activation. Elucidating the Cripto-1/EGF-CFC mechanism of ligand capture and oncogenic activation could
reveal epitopes and modalities to target Cripto-1 in cancers. In Aim 2 we will identify the ligand binding
determinants of the `type II' TGF-β family receptor BMPRII and establish functional consequences of ligand
binding-competition for BMPRII mediated signaling and PAH. TGF-β family signals are transduced via SMAD
transcription factors. In PAH, BMPRII mediated SMAD1/5/8 signaling is reduced. Just how is not understood.
Our recent findings offer a clue. We discovered that ligands regulated by Cripto-1 or its homolog Cryptic bind
BMPRII with high affinity. Until now, BMPRII was believed to be a low affinity receptor for BMPs, a subclass of
TGF-β family ligands. We also found that high affinity ligands inhibit BMP dependent SMAD1/5/8 signaling by
competing for receptor binding. We hypothesize that Cripto-1/Cryptic ligands suppress BMPRII mediated
SMAD1/5/8 signaling in PAH by competing with BMPs for BMPRII binding. Demonstrating that binding-
competition promotes PAH phenotypes and identifying epitopes on ligands that contact BMPRII could lead to
development of inhibitors that prevent high affinity BMPRII ligands from competing with low affinity BMPs, and
thus could help restore BMPRII mediated SMAD1/5/8 signaling in PAH. Successful completion of these studies
could help open new avenues for targeting Cripto-1 in cancers and for restoring BMPRII function in PAH.

Public health relevance
PROJECT NARRATIVE Transforming Growth Factor (TGF)-β family proteins are essential for normal cell physiology, but can cause devastating diseases, including cancers and Pulmonary Arterial Hypertension (PAH). Here, we will elucidate how the TGF-β family `co-receptor' Cripto-1 regulates TGF-β family signaling and how BMPRII signaling is reduced in PAH. These studies will benefit human health by helping guide the design of inhibitors that could be used to target Cripto-1 in cancers, and by identifying ligands that could be inhibited in PAH treatment.